Reprogramming BCR Signaling

Project Summary This project concerns IL-4 receptor (IL-4R) reprogramming of antigen receptor (BCR) signaling in B cells. Much study of signaling in the past has focused on biochemical events triggered in naïve B cells by BCR engagement alone. This has led to identification of signalosome mediators that form the “classical” signaling pathway and play an important role in B cell activation, but, the study of naïve B cells does not consider interactions among receptors that determine the ultimate outcome of stimulation. We have shown that prior exposure to IL-4 alters the nature of subsequent BCR signaling in normal and in malignant (CLL) B cells. Following IL-4 treatment, an “alternate” pathway for BCR signaling is created that is completely signalosome-independent. The proposed study aims to identify the fundamental biochemical changes that are produced by IL-4 to establish the alternate pathway. Lyn is absolutely required for alternate pathway signaling, whereas it has been known for years that Lyn is not required for classical pathway signaling. An early event that is completely specific for alternate pathway signaling is phosphorylation of PKCδ by Lyn, which occurs only when BCR triggering follows IL-4 exposure in normal and malignant B cells. Curiously, levels of Lyn and PKCδ are similar in naïve and IL-4- treated B cells, indicating that protein components that interact after BCR reprogramming are available in naïve B cells, yet signaling via the alternate pathway does not occur in naïve B cells, only in IL-4-exposed B cells. This means that something occurs after IL-4R engagement that alters the relationship of key signaling mediators in such a way that activities/interactions that did not occur previously, do so now. This provides a discrete system with which to determine molecular changes responsible for creating the alternate pathway. We will do this by examining Lyn phosphorylation of PKCδ, using this as a key and unique signature of alternate pathway signaling. We will evaluate 2 principal possibilities: 1) Lyn or PKCδ is changed, whereby Lyn substrate preference is altered such that PKCδ is a more avid target vs PKCδ efficiency as a Lyn src kinase substrate is altered, leading to Lyn-PKCδ interaction and PKCδ phosphorylation; or, 2) PKCδ is translocated to a membrane site conducive to Lyn-directed phosphorylation leading to Lyn-PKCδ interaction and PKCδ phosphorylation. This proposal represents a new, molecular direction for an established line of study. The high reward in this study is a much deeper understanding of how B cells, including malignant B cells, actually become activated in the milieau of cytokines that are experienced physiologically and pathologically in vivo. The results of this study will point the way to further dissection of the mechanism responsible for alternate pathway signaling by determining whether the focus should be on changes in the nature of Lyn vs PKCδ, or changes in PKCδ location and translocation. This will reveal further insights into normal B cell activation as well as signaling in CLL cells.

Public health relevance
Narrative Antibody producing B lymphocytes become activated after contact with bacterial or viral antigens, a process that is enhanced by hormone-like cytokines. Cytokines generated by T lymphocytes, especially IL-4, alter the way in which antigens stimulate B lymphocytes; that is, they change the way subsequent antigen exposure is perceived so that new and different events take place intracellularly. In other words, IL-4 and similar factors change the way B cells respond to antigen, and the goal of this proposal is to identify the exact biochemical alterations that are responsible for the new signaling events that occur when antigen is contacted after IL-4.